Gravida traumatic brain injury (TBI) impacts neurodevelopment of the offspring

PROJECT SUMMARY
(FOR ADMINISTRATIVE SUPPLEMENT REQUEST)
Intimate partner violence (IPV) increases the risk of traumatic brain injury (TBI), because the physical assaults
target the head, neck, and face. Women, more than men, across socioeconomic, racial, educational, regional,
and other demographic variables are in harm’s way throughout their life and particularly during pregnancy.
When one partner is pregnant, the frequency and intensity of physical assaults increase and remain focused
on the head, neck, and face. But, the consequences of a TBI during pregnancy (gravida TBI; gTBI) on offspring
neurodevelopment are unknown. Isolated TBI elevates stress and inflammation, which are known to divert fetal
neurodevelopment with gestational exposure. The proposal goal is to provide proof-of-concept that gTBI can
disturb neurodevelopment, thereby establishing gTBI as an environmental risk factor for developmental
disorders. These studies cannot be performed in people or be derived from existing databases, thereby
warranting laboratory studies. Preliminary data from this research team showed live births, low male weaning
weight, distorted cortical circuity, reduced anxiety and depression, and a muted immune response principally in
male gTBI offspring. These results encourage further investigation of TBI timing with respect to pregnancy,
broader assessment of neuropsychiatric outcomes, enhanced neural circuit analyses, and molecular
investigations of cell and synaptic change. The extent of neurodevelopment disruption is compared to a
standard model of maternal immune activation (MIA) and respective controls. The central hypothesis of this
proposal is that TBI during pregnancy leads to disrupted neurodevelopmental trajectory in the offspring
that includes altered neurobehavioral performance, neurocircuit organization, and cell type-specific
molecular disturbances. To test this hypothesis, a diffuse TBI will be delivered to timed-pregnant mice at 5
and 12 days post-coitum and then follow male and female offspring in terms of: [Aim 1] birth outcomes,
offspring physiology, neurobehavioral phenotype; [Aim 2] neurocircuitry phenotype, and [Aim 3] synaptic
protein expression and cortical cell type specific gene expression (transcriptomics). Aim 1 will evaluate early
post-natal behaviors; cognition, anxiety, depressive-like, and sensorimotor gating in young adult; and social
behaviors in adult offspring. In Aim 2, cortical and hippocampal synaptic physiology and cortical connectivity
will be evaluated by electrophysiology and laser scanning photostimulation, and aligned with quantitative
neuronal morphology. In Aim 3, western blot quantification of synaptic proteins and cell type-specific
transcriptomics inform circuit development and molecular trajectories. Impact: Successful completion of the
proposed studies will provide the first proof-of-concept that consequences of TBI during pregnancy, often
resulting from IPV, can distort developing brain circuity and determine a neurodevelopmental disorder
behavioral phenotype.

Public health relevance
PROJECT NARRATIVE (FOR ADMINISTRATIVE SUPPLEMENT REQUEST) Intimate partner violence includes assault to the head, neck, and face, with approximately 90% of survivors reporting symptoms concordant with persistent post-concussion symptoms, wherein pregnancy is associated with increased intensity and frequency of physical assault. Like stress, drugs, and inflammation, traumatic brain injury (TBI) during pregnancy can increase the environmental risk for neurodevelopmental disorders in the children. The proposal extends strong proof-of-principle results to explore the outcomes of gravida TBI in mice on the neurobehavioral, neurocircuitry, and molecular phenotypes of offspring to better inform science, education, and policy making.